Cardiovascular Sciences Training Grant

PROJECT SUMMARY
The Cardiovascular Sciences Training Program (CSTP) at the University of Chicago provides both pre-doctoral
and post-doctoral training. The postdoctoral trainees who participate in the CSTP include both M.D. and Ph.D.
trainees. The M.D. trainees are physician scientists most commonly recruited from the Cardiology Fellowship
Program at the University of Chicago, and the Ph.D. trainees have received their graduate degrees in diverse
areas and seek additional training in the cardiovascular sciences. The CSTP also supports pre-doctoral
training, an element essential to this integrated training program. The post-doctoral training strikes a balance
between clinically-trained M.D. fellows who plan careers combining research with clinical medicine, and
outstanding Ph.D. fellows who are dedicated to cardiovascular research. The CSTP offers training in six core
components:
1) Molecular Cardiology and Cell Signaling
2) Genetics/Genomics of the Cardiovascular System
3) Development, Stem Cell Biology & Regeneration
4) Cardiovascular Imaging and Translational Biology
5) Vascular Biology & Inflammation
6) Systems Biology and Bioinformatics
Each of these areas has as its scientific mission furthering our understanding of cardiovascular function in
health and disease. To this end, participants in this training program receive didactic, laboratory-based, ethics,
and analytic training in order to prepare for careers in cardiovascular research. We propose to continue
supporting 3 pre-doctoral and 6 post-doctoral trainees. The range of experience for the post-doctoral trainees
ranges from 0 to 6 years of post-doctoral training since M.D. fellows have often completed postgraduate
medical training at the time they begin in full time research in the CSTP. In the last training period, we
emphasized programs in genetic and genomics reflecting the growth in these fields and their successful
application to the cardiovascular sciences. We also enriched training opportunities in regenerative sciences
since important advances have been made for cardiac and vascular biology in this area. In this next interval,
we have additionally enlisted trainers with accomplishments in systems biology and analysis responding to
needs to take better advantage of emerging and existing “big data” and the expertise on the University of
Chicago campus. Systems analysis will be integrated with cardiac genetics and development and regeneration
biology, since these topics are critical to define the normal and abnormal function of the heart.

Public health relevance
PROJECT NARRATIVE The Cardiovascular Sciences Training Program is dedicated to preparing the next generation of scientists who aim to understand the normal and abnormal function of the heart and vascular system. Heart and vascular diseases remain a leading killer of Americans, and therefore, we need to have investigators who are well trained in this field. As cardiovascular disease has evolved and our understanding of it has changed, over this next training period, we have added mentors who are experts in bioinformatics and systems analysis to take better advantage of large biomedical data sets that will help us better diagnose and treat cardiovascular disease.